Hybridization Chain Reaction: Automated Ultrasensitive Multiplex RNA and Protein Imaging

Project Summary
Hybridization Chain Reaction:
Automated Ultrasensitive Multiplex RNA and Protein Imaging
Encoded in the genome of each organism, biological circuits direct development, maintain integrity in the face of
attacks, control responses to environmental stimuli, and sometimes malfunction to cause disease. RNA in situ
hybridization (RNA-ISH) and immunohistochemistry (IHC) methods provide drug developers, pathologists, and
biologists with critical windows into the spatial organization of this circuitry, enabling imaging of RNA and protein
expression in an anatomical context. While it is desirable to perform multiplex experiments in which a panel of
targets is imaged with single-molecule sensitivity at low magniﬁcation over a large ﬁeld-of-view within intact tissue,
the dominant automated RNA-ISH and IHC methods struggle to provide these capabilities. First, multiplexing
is cumbersome, requiring serial enzyme-mediated signal ampliﬁcation for each target in succession (currently
limited to 2-plex for chromogenic staining of RNA targets and often requiring probe stripping for protein targets).
Second, sensitivity is routinely limiting at the low magniﬁcations essential to rapid screening of large ﬁelds-of-view;
this problem is only exacerbated for short RNA targets, low-expression targets, and archival tissue sections. Third,
there is no uniﬁed technology for automated imaging of RNA and protein targets. Current automated RNA-ISH
approaches require a protease pretreatment step that digests proteins to enable large reagents to penetrate the
sample; this digestion step comes at a high cost both because it damages the tissue morphology and because it
makes it challenging or impossible to image protein targets in the same sample. Collectively, these multi-decade
technology gaps are signiﬁcant impediments to drug development, clinical pathology, and biological research,
undermining multi-dimensional analyses of genetic regulatory networks in an anatomical context.
To overcome these challenges, in situ ampliﬁcation based on the mechanism of hybridization chain reaction
(HCR) draws on concepts from the emerging discipline of dynamic nucleic acid nanotechnology to provide the
ﬁrst uniﬁed framework for simultaneous RNA and protein imaging, achieving multiple breakthroughs to enable
multiplex, quantitative, high-resolution RNA and protein imaging in highly autoﬂuorescent samples. To empower
high-velocity biopharma drug development and clinical diagnostics workﬂows, the proposed R&D will build on the
unique capabilities of HCR to: 1) engineer a novel chromogenic signal ampliﬁcation cascade to enable automated
ultrasensitive 4-plex RNA chromogenic in situ hybridization (RNA-CISH), IHC, and simultaneous RNA-CISH/IHC
at low magniﬁcation for rapid whole-slide scanning, 2) engineer a novel enzyme-free ﬂuorescent signal ampli-
ﬁcation cascade to enable automated ultrasensitive 4-plex RNA ﬂuorescence in situ hybridization (RNA-FISH),
immunoﬂuorescence (IF), and simultaneous RNA-FISH/IF at low magniﬁcation for rapid whole-slide scanning.
These capabilities will enable drug developers, pathologists, and biologists to perform automated, ultrasensi-
tive, multiplex analyses of RNAs and proteins in an anatomical context using either chromogenic or ﬂuorescent
workﬂows.

Public health relevance
Project Narrative Hybridization Chain Reaction: Automated Ultrasensitive Multiplex RNA and Protein Imaging We propose to engineer and commercialize molecular technologies that will enable automated, ultrasensitive, simultaneous imaging of multiple RNA and protein molecules within sample types critical to drug development, clinical pathology, and biological research. The resulting products will enable the development of new therapies, the clinical diagnosis of disease, and the study of human biology and disease.